Long-lived highly differentiated monocyte-derived cells (LDMs) activate lung-resident CD8+ T cell memory

PROJECT SUMMARY/ABSTRACT
The lung, as it is constantly challenged, has a unique immune system, much of which is still underappreciated.
Respiratory viral infection, including influenza and SARS-CoV-2, is among the worst burdens of disease
worldwide and in the US, and especially viral pneumonia is one of the leading causes for irreversible tissue
damage and death. Importantly, immune responses of the lung to the viral infection determine the outcome of
these viral illnesses, so better understanding of the lung immunology is warranted.
CD8+ T cells are the most important immune effector against viral infection of the respiratory organs because
they significantly reduce virus burden and spread by eliminating infected cells. But T cell immunity is not an
autonomous system and innate immune cells are required for the T cells to be functional. In the lung, dendritic
cells (DCs) and macrophages play such regulatory roles in general. I had previously demonstrated that tissue-
infiltrated monocytes are also important for efficient T cell immune responses during influenza infection of the
lung and trachea, adding to the knowledge of innate immune regulation of T cell responses.
Now I have strong evidence that the monocytes infiltrating into the lung during influenza virus infection further
differentiate into a novel myeloid cell type, long-lived highly differentiated monocyte-derived cell (LDM), and the
LDM cells persist in the lung for many months since recovery from the infection. I also obtained preliminary, but
significant, data indicating that those LDM cells are a key regulator of lung-resident memory T cell (TRM). TRM is
an effective cytolytic immune effector to protect hosts from recurrent infection, however current understanding
of regulatory mechanisms for lung-resident T cell memory remains insufficient. We will address an unsolved
issue in this field–how lung TRM is regulated by innate immunity.
In Aim 1, it will be tested if LDM, not conventional DCs, activates lung TRM upon recurrent influenza infection
using a LDM depletion mouse model that I newly developed. In Aim 2, I will investigate the mechanism(s) by
which the LDM activates TRM. Through rechallenge of virus-immune mice with viral antigens, reconstituted in
vitro cell assays and reporter assays that distinguish cytokine signals and TCR activation signal, it will be
determined if the LDM is a lung-resident antigen presenting cell (APC) type for TRM activation. In Aim 3, to
corroborate evidence that the LDM promotes TRM activation, interaction, migration and tissue localization of LDM
and TRM in the lung will be investigated using cutting-edge lung imaging technologies.

Public health relevance
PROJECT NARRATIVE Respiratory virus infection remains a great threat to humans and effective therapies for this infection are still limited, requiring significant improvement in our understanding of lung immune mechanisms against illnesses that respiratory viruses induce. I have, for the first time, developed the tool to track long-term fates of monocytes and then found that a novel monocyte-derived myeloid cell type populates the lung recovered from influenza infection. In this project, I will determine that this newly-identified cell population protects hosts from infection by promoting lung-resident T cell memory, thereby helping development of effective medical strategies such as new vaccine formulae to strengthen lung immune memory against respiratory viral diseases.